Exposomic Approach to Identifying WTC Exposures and Effects in Survivor Youth.

PROJECT SUMMARY
Pregnant women and children who lived, worked or attended school near the World Trade Center (WTC) on
September 11, 2001 experienced a variety of psychological and chemical exposures with potential adverse
consequences for later health and development. In contrast to psychological effects, physical health effects of
early life exposure to the World Trade Center (WTC) disaster remain poorly understood. This is particularly
important as the well-known developmental origins of health and disease (DoHAD) concept indicates that
exposures occurring during sensitive developmental windows may lead to adverse health outcomes in later
life. We have recently demonstrated that neonates and children exposed to chemicals (e.g., dioxins,
perfluoroalkylsubstances (PFAS)) known to be associated with WTC experience adverse health outcomes
including adverse birth outcomes, altered lipid levels, and asthma. However, characterizing the totality of WTC
exposure—including both psychologicial and chemical exposures—has been challenging, limiting our ability to
identify WTC-related health effects, which are likely to emerge as exposed children age. Here, we employ
advances in molecular laboratory technology, which have enabled high-resolution methods to measure
thousands of exogenous chemicals and their endogenous biological responses to these exposures. These
powerful exposomic and metabolomic approaches have been used to enhance disease prognosis and diagnosis
as well as provide insight into disease pathogenesis in neonates, children and adults. Using two cohorts of WTC-
exposed neonates and youth, we can 1) identify an exogenous chemical signature that is associated with
conventional WTC exposure measures including proximity-based exposure metrics and targeted biomarkers
associated WTC exposure indices (Aim 1); 2) identify a metabolomic signature that reflects the biological
response to both conventional WTC exposure measures and psychological stressors associated with WTC
exposure (Aim 2); and 3) determine if WTC-exposure related exogenous chemical signatures (Aim 3a) and
metabolomic signatures (Aim 3b) are associated with adverse health outcomes in children. If confirmed, the
exogenous chemical and metabolomic signatures we identify in blood stored from these two vulnerable WTC-
exposed populations will provide unique fingerprints that can be used to predict adverse WTC-related outcomes
that may emerge as exposed children age into adulthood.

Public health relevance
PROJECT NARRATIVE Characterizing the totality of WTC exposure—both psychological and chemical—has been challenging, particularly among pregnant women and children, which has limited our ability to identify WTC-related health effects. New advances in high resolution gas chromatography can characterize WTC-related exposure and biological response to exposure in ways that were previously impossible. This study uses novel metabolomic and exposomic methods to characterize WTC exposure and the effects of WTC exposure among those who were exposed in utero or as children, two sensitive windows of development.